PFAS and Diabetic Kidney Disease in Young Onset Type 2 Diabetes: Emerging Risk Factors and Underlying Mechanisms

PROJECT SUMMARY / ABSTRACT
Diabetic kidney disease (DKD) develops in more than 50% of youth with type 2 diabetes (T2D) as they transition
to young adulthood. Early identification of youth at risk of DKD, either due to environmental or biological factors,
has the potential to inform clinical care and alter the course of disease. Despite the substantial burden of DKD
in youth with T2D, however, modifiable risk factors and effective therapies remain limited. Emerging evidence
links per- and polyfluoroalkyl substances (PFAS), a group of ubiquitous artificial chemicals used for more than
60 years in consumer and industrial products, with impaired kidney function, worse glucose regulation, and
higher levels of uremic toxins, key risk factors for DKD in youth with T2D. This study proposes to perform the
first prospective study to examine the association of PFAS exposure with DKD risk in youth with T2D and to
investigate potential biological mechanisms by integrating key information on metabolites and protein levels. The
project will build upon existing health and omics data (metabolomics and proteomics) in the Treatment Options
for Type 2 Diabetes in Adolescents and Youth (TODAY) study, a longitudinal study of youth with T2D who
underwent annual measures of kidney function for an average of 10.2 years. Using archived plasma samples,
this project will measure levels of 10 common PFAS and up to 250 novel and emerging PFAS at baseline. Due
to the long biological half-lives of most of these chemicals, single PFAS measures are a good proxy for medium
to long-term PFAS exposures. Analyses will examine associations between individual PFAS and PFAS mixtures
with risk and progression of DKD using survival analysis and mixture methods. To examine the potential
biological pathways that link PFAS exposure with DKD, analyses will then examine associations of PFAS
(individual and mixtures) with metabolites and proteins potentially associated with DKD risk. Further, a novel
latent unknown clustering approach will be applied to comprehensively analyze PFAS exposure, multiomics, and
clinical data to identify subgroups of youth with T2D at high risk of DKD. These research findings will contribute
to the body of evidence needed to inform PFAS regulation and develop innovative environmental health
interventions to detect and prevent DKD in youth with T2D. The culmination of my scientific training has prepared
me to successfully carry out the proposed K01 research. Through a multifaceted training plan supported by a
strong transdisciplinary mentoring and advisory team, this K01 will provide the necessary support for me to
further develop as an independent environmental health researcher. In addition to the proposed research project,
a robust yet attainable training plan incorporating didactic instruction, seminars, conferences, and mentorship
will prepare me to successfully complete a future NIEHS R01 to examine personalized DKD prevention strategies
in young individuals, when potential lesions may still be reversible, to promote healthier lives in this at-risk
population.

Public health relevance
PROJECT NARRATIVE Youth-onset type 2 diabetes significantly contributes to the increasing prevalence of diabetic kidney disease, yet our understanding of modifiable risk factors remains limited. This study seeks to explore the role of exposure to per- and polyfluoroalkyl substances (PFAS), an emerging environmental risk factor, in the onset and progression of diabetic kidney disease among youth with type 2 diabetes by integrating data on PFAS exposure with data on metabolites and proteins linked to uremic toxicity. This research project will enhance understanding of the health impacts of PFAS, thereby supporting PFAS regulation and helping develop innovative strategies for early identification and prevention of diabetic kidney disease.